RFA-TS-24-010: Ambient Air Pollution as a Potential Risk Factor for ALS - Using a Multiomics Approach in a High-Quality Epidemiologic Study

Project summary
Air pollution is gaining momentum as an important contributor to ill health and has recently started to be studied
as a potential risk factor for amyotrophic lateral sclerosis (ALS). The currently existing literature is, however,
limited by methodological limitations, and the underlying mechanisms linking together air pollution and the
initiation and progression of ALS are still largely unknown.
With the ultimate goal of providing important new knowledge for disease prevention among high-risk individuals
and identifying novel therapeutic targets, the overarching aim of this research project is to use the extensive data
and biospecimens collected in a unique Swedish national ALS registry to identify and evaluate air pollution, alone
or together with another proposed risk factor for ALS, namely infections, as a potential risk and prognostic factor
for ALS, focusing on understanding alterations in the expression of proteins related to oxidative stress and
inflammation, the immune responses, and the gut microbiome as potential underlying mechanisms.
In the specific Aim I, we will assess the role of air pollution, alone or together with infection, on the risk and
prognosis of ALS, using prospectively and independently collected data from the Swedish national health
registers (including the Motor Neuron Disease [MND] Registry). We will contrast ALS patients of different clinical
phenotypes with two control groups: disease-free full siblings and age- and sex-matched population controls. In
the specific Aim II, we will characterize the role of air pollution, alone or together with infection, on 1) the
expression of proteins related to oxidative stress and inflammation in blood and cerebrospinal fluid (CSF) and 2)
the composition and functionality of the gut microbiome in ALS patients, compared to controls, using the ALSrisc
Study. In the specific Aim III, we will use single-cell RNA sequencing to profile the immune cells of blood and
CSF to understand the role of air pollution, alone or together with infection, on immune responses in ALS.
In summary, this proposal addresses both of the two objectives listed by NOFO RFA-TS-24-010, namely 1)
Identify potential risk factors for ALS in humans and 2) Characterize how or why the(se) risk factors are potentially
associated with or contribute to the etiology, progression, and pathophysiology of ALS in humans.
Findings from this project are expected to advance our understanding of ALS as a disease and provide new
knowledge for disease prevention and treatment, fully supporting the ATSDR National ALS Registry's mission.
The findings will also help ATSDR better prioritize topics for future research initiatives and inform the
development of new ATSDR National ALS Registry risk factor surveys for persons with ALS.
Finally, the proposed program of research also addresses the Healthy People 2030 priority area of environmental
health infrastructure and surveillance and is in alignment with CDC/ATSDR’s performance goal to conduct a
targeted program of research to identify, characterize, and monitor health outcomes and environmental
exposures to guide actions that protect and promote health. Specifically, our research supports the Healthy
People 2030 goal to promote healthier environments and Healthy People Objective EH-06 to reduce the amount
of toxic pollutants released into the environment.
The research proposal intends to fall under Funding Option B: to support novel ALS risk factor research
investigations that may or may not have an existing evidence base, maybe supported by limited and
insufficient preliminary research, and are exploratory and developmental in nature.

Public health relevance
Project narrative Undisputedly, ALS is one of the worst diagnoses for doctors to give and for patients to receive, due to its rapid progression and the current lack of therapeutic options. Identification of potential non-genetic risk factors for ALS, especially the modifiable ones, is therefore of paramount importance in providing new knowledge for disease prevention among high-risk individuals and identifying novel therapeutic targets. Hence, this project aims to use high-quality epidemiological research resources in Sweden, in combination with state-of-the-art molecular technologies and data science, to identify and evaluate air pollution, alone or jointly with infections, as a potential risk and prognostic factor for ALS, focusing on characterizing how and why air pollution could be associated with ALS and contribute to the etiology, progression, and pathophysiology of ALS in humans.